Regulation Of Opioid Receptor Signaling by Endogenous Peptides

The current opioid epidemic highlights the need for a deeper understanding of how opioid receptors are
activated in our body. Our knowledge about the downstream events following opioid receptor activation comes
mainly from studies on opiates (e.g., morphine), synthetic drugs (e.g., fentanyl), and modified peptides (e.g.,
DAMGO). While these studies are important, the physiological ligands of the opioid receptors are endogenous
opioid peptides such as endorphins, enkephalins, and dynorphins. Over 20 different opioid peptides have been
identified in the brain, all of which activate the three types of opioid receptors (µOR, dOR, kOR) albeit with
different affinities and efficacies for G protein-mediated versus β-arrestin-mediated signaling pathways. Thus,
endogenous opioid peptides show biased agonism, a property previously found for opiates and synthetic opioids.
Recent efforts to design safer opioid drugs were focused on optimizing G protein-mediated over β-arrestin-
mediated pathways. However, this is overly simplistic because respiratory depression and other negative side
effects of opioids have been shown to be G protein-dependent. Also, the model does not consider the possibility
that ligands can preferentially activate different subtypes of G proteins and downstream mediators. Another
factor that contributes to divergent signaling is agonist-mediated post endocytic signaling after receptor trafficking
to endosomes followed either by lysosomal degradation versus recycling to the cell surface. Because
endogenous opioid peptides are widely considered to be less toxic than opioid drugs, it is important to know the
signaling properties of these peptides in comparison to representative opioid drugs.
In this application we describe studies to characterize signaling by opioid peptides at individual receptor
types. Based on preliminary data we hypothesize that “each opioid peptide exhibits a distinct signaling
profile at each receptor type resulting in the expansion of opioid receptor signaling repertoire”. To test
the hypothesis, in Aim 1 we will investigate the specific signaling pathways activated by individual opioid peptides
and compare them to a selected set of opioid drugs that range in addiction potential and toxicity. In Aim 2 we will
examine receptor trafficking and endosomal signaling upon activation by individual opioid peptides in comparison
with a selected set of opioid drugs. In both Aims we utilize a combination of classic and modern techniques to
study the effect of opioid peptides on cell lines expressing defined opioid receptors and signaling proteins,
followed by electrophysiological analysis of brain regions important for rewarding effects (ventral tegmental area)
and toxicity such as respiratory depression (the Kölliker Fuse nucleus). Together, these studies will broaden our
understanding of opioid receptor signaling in response to their biological ligands, laying the groundwork for safer
novel therapeutics for the treatment of pain, substance use disorders, and other disorders that involve the
endogenous opioid system.

Public health relevance
Drugs that activate opioid receptors are widely used as analgesics, but they can cause serious problems such as opioid use disorder and respiratory depression. The vast majority of studies on opioid receptors have used exogenous ligands, and only a few studies have investigated the biological peptides that normally activate the receptors in the body. We will study the signaling induced by endogenous opioid peptides versus representative opioid drugs, in order to identify potential target mechanisms for developing better analgesics with fewer unwanted side-effects.